Effects of marijuana use on inflammation and vascular injury in adults with HIV infection

Project Summary
The goal of this proposal is to characterize biomarkers of marijuana smoke exposure in ART-treated HIV+
adults over age 40, and their relationship to inflammation and vascular injury in heavy users. Marijuana and
tobacco smoking are both prevalent among HIV+ populations, but their individual and combined impacts on
inflammation and cardiovascular risk are unknown. Preliminary studies using longitudinal data from a
prospective cohort showed that chronic heavy marijuana smoking has no significant effect on HIV disease
markers, but is associated with increased rates of incident cardiovascular events in ART-treated HIV+ men age
40-60 independently of tobacco smoking and traditional risk factors. Furthermore, we showed that heavy
marijuana and/or tobacco smoking was associated with elevated WBC and neutrophil counts, immune
activation, inflammation, and vascular injury in ART-treated HIV+ smokers. We hypothesize that specific
combustion products in marijuana and tobacco smoke, including acrolein, other reactive aldehydes, and VOCs,
can induce proinflammatory responses mediated through activated neutrophils and monocytes that promote
chronic inflammation in ART-treated adults, contributing to cardiovascular risk by promoting lipid peroxidation,
coagulation, vascular inflammation, and endothelial injury, while attenuating protective responses. We further
hypothesize that these effects are additive upon dual exposure to both marijuana and tobacco smoke and
augmented by HIV infection. To address these questions, we will use clinical samples and data from well-
characterized longitudinal HIV+ cohorts to characterize marijuana smoke exposure biomarkers in plasma and
urine samples and their relationship to inflammation, oxidative stress, and vascular injury. Bioinformatics,
computational modeling, and cell culture models will be used to build and test models to explain the effects of
specific constituents of marijuana smoke on inflammatory pathways, and how these pathways are modified in
the setting of HIV infection. These studies will provide information that helps to explain chronic inflammation
and elevated cardiovascular risk in ART-treated HIV+ adults, safety profiles of smoked cannabinoids, and
potential strategies for therapeutic intervention.

Public health relevance
Project Narrative The goal of this proposal is to characterize markers of marijuana smoke exposure in ART-treated HIV+ adults over age 40, and their relationship to inflammation and vascular injury in chronic heavy users. These studies will elucidate mechanisms by which smoked marijuana can impact inflammation and health outcomes in HIV+ individuals, and provide new information related to safety profiles of cannabinoids and development of therapeutic interventions.